Summer Institute in Cognitive Neuroscience

DESCRIPTION (provided by applicant): For 22 years, the Summer Institute in Cognitive Neuroscience has brought together leaders in Cognitive Neuroscience and promising graduate students, post-doctoral researchers and young professors/scientists for an intensive, two-week lecture and laboratory course aimed at topics on the cutting-edge of the discipline. This proposal seeks five years of funding for the program's continuation. The Summer Institute focuses on staying up-to-date with the field's latest advancements and exposes its participants to the latest rapidly emerging methods and discoveries. Through a combination of lectures, debates, close interaction among Institute attendees, and laboratory demonstrations, using advanced techniques such as functional neuroimaging, transcranial magnetic stimulation, and event-related potentials, participants are provided with an intense and rich exposure to a broad array of techniques and approaches bisecting all fields bearing on the mind and brain. The intensely interdisciplinary nature of the Summer Institute is its most defining feature and valuable asset. The next 5 years of the Institute will continue its successful traditions, while also providing innovations to significantly augment and enhance the program. The Summer Institute in Cognitive Neuroscience provides an essential service to the field by providing the nation's young scientists with unique training that fosters interdisciplinary perspective and collaboration, and by encouraging cross-disciplinary exchange between established scientific leaders and young, promising researchers. The Institute contributes directly to the advancement of the field by calling attention to and advancing knowledge of issues at the frontiers of current discovery that are relevant to the mission of the NIH in basic and translational research and training.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will provide intensive training in the principles, theories and methods of cognitive neuroscience that are relevant to both healthy individuals and individuals suffering from disorders of the mind and brain, from infancy through old age. This enhanced training will allow scientists to make more rapid progress in understanding the operation of the normal brain and in understanding a variety of mental and neural disorders, which will ultimately lead to improved diagnosis of these disorders, as well as improved assessments of new treatments. Relevance This project will provide intensive training in the principles, theories and methods of cognitive neuroscience that are relevant to both healthy individuals and individuals suffering from disorders of the mind and brain, from infancy through old age. This enhanced training will allow scientists to make more rapid progress in understanding the operation of the normal brain and in understanding a variety of mental and neural disorders, which will ultimately lead to improved diagnosis of these disorders, as well as improved assessments of new treatments. __SpecificAimsTextDelimiter__ 2. Specific Aims The objectives of the Summer Institute in Cognitive Neuroscience are to advance the cognitive neurosciences by training the next generation of researchers in emerging information, methods and theoretical perspectives in mind-brain science, including how this knowledge can be applied in translational research. The proposed Summer Institute includes innovations in training, and will be an intense, rapidly adapting program that trains promising senior graduate students, post-doctoral fellows, and young professors and research scientists in work at the cutting edge of the discipline. Diversity in the faculty and trainees is highly valued in the Summer Institute, and ethical training is now built into the curriculum, as is rigorous new evaluation of the outcome success of the training program. The Summer Institute aims to foster interdisciplinary research among the next generation of scientists, and to help scholars apply such approaches to research that addresses pressing public health issues in human neuroscience and mental health. The specific aims of the Summer Institute are as follows: (1) To provide training in the most current information in cognitive neuroscience. Cognitive neuroscience is broad in its scope, and rapidly evolving. Concepts of cognitive brain function change rapidly as new information on complex higher mental functions are investigated and understood. The Summer Institute organizes training from leading scientists and promotes debate on critical issues. A hallmark of the Summer Institute is to juxtapose opposing views of cognitive brain function, and deliberately involve the fellows in debate and critical thinking. (2) To foster interdisciplinary research training. Cognitive neuroscience is an intrinsically interdisciplinary enterprise. Continued progress in our understanding of the brain, mind, and human behavior is only going to be possible if researchers from all fields bearing on these topics exchange ideas and collaborate extensively. The Summer Institute greatly values the interdisciplinary nature of its faculty, participants, and curriculum. In the next five years, the Summer Institute will continue these efforts, expanding them to include a wider array of disciplines, and to advance translational research training. (3) To expand exposure to and training in recently emerging technologies. Much of the progress in our current understanding of the relationship between the brain and mind has been made possible by steady advancement in electrophysiological and magnetic recording methods, structural and functional brain imaging, transcranial magnetic stimulation, and genetic, molecular and mathematical methods. Major advancements are being made in the ways in which researchers analyze and interpret the data produced by these techniques, and the means by which they are integrated. The Summer Institute will include innovations in training to provide up-to-date information and debate on the latest techniques by giving its participants both theoretical training and hands-on experience with these methods. One such innovation is the inclusion of methods lectures and experiences in each institute that specifically address the topic(s) of that institute. In the next 5 years, the Institute will focus on the most promising of currently developing methods, including multimodal brain imaging, new methods for the analysis of fMRI/MRI data, diffusion tensor imaging, structural quantitative image analysis, genetic and molecular methods, and modeling. (4) To address the important ethical implications of cognitive neuroscience research. Historically, cognitive neuroscience has focused on traditional topics in cognitive psychology, such as perception, attention, memory, decision making, cognitive control, and language. In recent years, the ethical implications of this work have come to be more deeply appreciated, and topics as varied as economic decision making, drug addiction, moral conscience, and racial prejudice are informed by cognitive neuroscience research. An innovation is the inclusion of lectures and discussions of ethical issues of importance to cognitive neuroscience that will be led by leaders in the emerging field of neuroethics.